Multi-cancer Early Detection

PROJECT SUMMARY/ABSTRACT
Cancer is a leading cause of mortality in the U.S. Screening reduces mortality from several of the most
common (colorectal, breast, uterine cervix, and lung) cancers but most cancer types, accounting for 70% of
cancer deaths, are not screened due to limitations in technology and low positive predictive value, driven by
low incidence of each individual cancer type. It has been argued that multi-cancer detection tests might
address this critical long-term gap in population health. To avoid false-positive results, commercial multi-cancer
test developers train performance on high specificity goals at the penalty of low sensitivity for early-stage
cancers, and current tests may more or less accurate depending on the organ/type of cancer. This application
proposes to use unique sample archives to address key scientific questions. Specifically, there are relatively
limited assessments of 1) how well and at what interval multi-cancer test predict the development of clinical
cancer (indolent vs lethal) among asymptomatic individuals (prediagnostic performance study); 2) how to
evaluate or validate promising liquid biopsy-based biomarkers in various risk populations; and, 3) how to
facilitate the development of high-throughput, sensitive assay methods to validate biomarkers that are useful in
early detection of early-stage cancers or their lethal precursors. This application is in direct response to NOSI
(NOT-CA-23-004) “Utilization of Cohorts and Prospective Study Designs for Liquid Biopsy Assay Validation for
Early Detection of Cancers,” in which NCI has encouraged partnerships between technology developers and
population-based cohort/biorepository researchers to facilitate multi-cancer detection test investigations in the
appropriate populations, and encouraged applications that investigate the use of existing cohort samples and
samples from ongoing prospective collections for analytical and clinical validation of assays for earlier
detection of cancer. With our biomarker candidate marker library, extensive sample archive, and unique
access to a state-of-the-art assay and analytical platforms, accelerated implementation of multi-cancer
detection testing in clinical practice is anticipated by addressing impactful scientific questions beyond the
tactical focus of the commercial lens.

Public health relevance
PROJECT NARRATIVE In the United States, cancer is the leading cause of death for persons under 80 years of age. Screening of persons without cancer symptoms is only practiced for colorectal, breast, cervical and lung cancer and saves lives. This proposal will address key questions surrounding a new cancer screening concept, the multi-cancer detection test which might facilitate screening for additional cancer types by measuring cancer cell-free DNA to detect multiple cancer types from a single venous blood draw.